In vivo functional characterization of a novel protein encoded by a lncRNA

Project Abstract/Summary
Understanding the mechanisms that underlie the function and regulation of immune cells in health and disease
is critical to developing therapies aimed at modulating their function. Innate immune cells such as macrophages
represent a critical arm of the immune system. These cells not only represent the front line of defense against
microbes, but also mediate critical effector functions at the direction of the adaptive immune system.
Dysregulation of such effector functions can lead to pathogenic inflammation and tissue damage, as seen in
septic shock, an acute condition that results in the death in one out of three affected patients. Thus,
understanding the functional regulation of these cells can help to develop therapeutic interventions for such
diseases. Classic protein coding genes represent a minority of genetic elements in the eukaryotic genome, and
yet these genes have been the focus of the vast majority of functional studies to date, including those
investigating innate immune cell function. Surprisingly, the number of such genes does not increase with
organismal complexity, while the number of so-called non-coding genes does. A class of such genes, called long
non-coding RNAs (lncRNAs) have recently emerged as critical regulators of immune cell function. We have
identified such a lncRNA, called U90926, as almost exclusively expressed in activated myeloid cells. We found
that this lncRNA can also serve as an mRNA, encoding a novel secreted protein. The source, localization, and
function of this protein in vivo is unknown, and represent a significant challenge and a key next question. Here
we propose to generate novel mouse models to address all three of these questions in vivo, in models of septic
shock.

Public health relevance
Project Narrative Despite their abundance, the specific functions of most long non-coding RNAs (lncRNAs) in health and disease remain unknown. We propose to develop new mouse models to characterize in vivo the localization and function of a newly discovered small protein encoded by a myeloid cell-specific lncRNA called U90926.